Core 1 - Administration

Core 1. Project Summary. Core 1 will provide the administrative coordination, oversight, and logistical support for the entire Conte Center. It will hire a part-time administrative staff (Dr. Remya Nair) who is currently laboratory administrator for the PI and whose duties already entail grant management, coordination with the Caltech Brain Imaging Center, and supervision of other staff. This Core includes support for visits of all the PIs to Caltech for annual meetings, visits for the Advisory Board to Caltech annually, and continued maintenance of our website dedicated to the Conte Center. There are three Aims: to coordinate and communicate internally among all the investigators of the Conte Center to facilitate the science proposed; to coordinate the best teaching and training of graduate-students, post-docs, and undergraduates; and to coordinate and communicate between the investigators of the Conte Center and the outside research community, NIH, and the larger public.